NASAL ELECTRIC POTENTIAL DIFFERENCE IN NORMAL AND CYSTIC FIBROSIS PATIENTS

The goal of this study is to evaluate the significance of the transepithelial voltage across the nasal epithelium in normal subjects, patients with cystic fibrosis (CF), and non-CF patients with bronchiectasis.